Gamma Sensory Flicker as an Early Intervention for Alzheimer’s Disease: Mechanisms and Protective Effects

Gamma Sensory Flicker as an Early Intervention for Alzheimer's Disease: Mechanisms and Protective
Effects
Alzheimer's disease (AD) requires a new therapeutic approach to intervene prior to or early in the disease. In
the previous funding period, the PI and team discovered that gamma, or 40Hz, sensory flicker (lights and sounds
turning on and off with millisecond precision) has beneficial effects in mouse models of Alzheimer's pathology at
symptomatic stages. Gamma flicker drove gamma neural activity, reduced amyloid plaques, recruited microglia
to engulf amyloid beta (Aβ), and restored memory behavior in mice with Aβ pathology. This proposal marks the
exciting shift of this research to intervene in AD during the preclinical stages prior to plaque accumulation and
the onset of memory deficits. Microglia and cytokines play a disease modifying role in AD and affect network
function, with potential damaging or beneficial effects. Recent research, from our team and others, reveals
protective immune gene and protein signatures in early AD pathogenesis. The goal of this proposal is to
determine how flicker stimulation affects protective immune function in preclinical AD stages to improve neural
signatures of memory and to elucidate the mechanisms of these effects. Using cutting edge transcriptomic and
proteomic analyses and large-scale neural recordings, we will determine the effects of flicker on microglia
phenotypes and neural signatures of memory. Using pharmacological and genetic manipulations, we will
determine the causal role of microglia and microglial signaling in mediating flicker's effects on microglia
phenotype and network function. We will determine if flicker-induced microglia gene transcription overlaps with
recently defined human anti-inflammatory microglia markers present in early AD, using our teams' discoveries
from cutting edge cell-type specific analysis of human tissue. Aim 1 will define the effects of flicker on microglia
phenotype at preclinical stages, the molecular mechanisms involved, and the human-relevant transcriptional
effects. Aim 2 will establish how preclinical flicker affects neural signature of memory integration during learning
and the causal role of microglia in this process. This research will result in a paradigm shift to use noninvasive
brain stimulation prophylactically in people at risk of AD prior to plaques or symptoms. Furthermore, this research
will reveal new mechanisms by which flicker stimulation promotes protective immune function and promotes
memory.

Public health relevance
The proposed research will provide a new approach to early intervention for Alzheimer's disease by stimulating neural activity early in or prior to disease onset. This research will reveal mechanism by which non-invasive brain stimulation promotes protective immune functions and memory processes.